NEW HORIZONS IN THE PREVENTION AND TREATMENT OF FOOD ALLERGY

Project Summary:
Food allergy affects approximately 5-10% of young children, with highest incidence in the first
year of life. Food allergy accounts for almost $25 billion per year in U.S. costs. Atopic dermatitis
[AD] (also known as eczema) is a major risk factor for food allergy and other allergic diseases,
and also has a significant intrinsic impact on child health. AD affects approximately 13% of U.S.
children, of whom approximately 1/3 have moderate to severe disease. AD is a chronic disease
characterized by skin barrier disruption and inflammation, with ongoing major effects on the
quality of life of children and families. Currently, there is no reliable way to identify those infants
destined to develop atopic disease who would benefit from targeted prevention strategies. The
goal of this study is to establish a birth cohort that collects prenatal and early life environmental
and bio-samples and rigorously phenotypes young children for food allergy and AD to identify
prenatal and early life markers of high risk for food allergy and AD.

Public health relevance
Narrative A cohort of 2500 unselected mother-infant pairs enrolled prenatally and followed to 3 years of age with the primary outcomes of development of (1) food allergy and (2) moderate-severe eczema in the first year of life, and secondary outcomes of (3) recurrent wheeze in the first 3 years of life, (4) sensitization to foods in the first year of life, (5) any eczema in the first 6 months of life, and (6) food allergy at 3 years of life.